Cancer Center Support Grant

RESEARCH PLAN – RUTGERS CANCER INSTITUTE OF NEW JERSEY OVERALL
PROJECT SUMMARY/ABSTRACT
The Rutgers Cancer Institute of New Jersey (CINJ) is a matrix/consortium (with Princeton University) and New
Jersey’s only NCI-designated Comprehensive Cancer Center, serving a diverse population of 8.9 million people.
CINJ focused the strengths and resources of the major research institutions in NJ on addressing the cancer
burden in its catchment area (NJ). The rapid trajectory of CINJ’s growth validated the initial vision that one of the
Nation’s largest public universities of the health sciences would rapidly bring forth an NCI-designated Cancer
Center. CINJ has 227 members (206 Rutgers, 19 Princeton, and 2 collaborating). The State Cancer Registry
and Surveillance, Epidemiology, and End Results (SEER) Program was moved to CINJ in 2011, and as a result
of state legislation in 2013, CINJ became an independent institute of Rutgers University, optimizing CINJ’s
potential for growth, transdisciplinary collaboration, and impact across the catchment area. In FY2018, CINJ
received over $68 million in support from Rutgers and Princeton, the State, the Health System, and philanthropy.
Direct peer-reviewed support increased ~16%. Members published 3,664 cancer focused publications since
2011 (20% inter- and 24% intra-programmatic, 55% inter-institutional). In January 2017, Steven K. Libutti was
appointed Director of CINJ and Vice Chancellor for Cancer Programs for Rutgers Biomedical and Health
Sciences (RBHS). In a strategic partnership with the RWJBarnabas Health System, Libutti was named Senior
Vice President for Oncology Services. CINJ is now positioned to coordinate both cancer research and care
throughout its catchment area. An iterative strategic planning process resulted in reorganization of research
Programs to increase collaborations, cancer focus, translation, and investigator-initiated clinical trials. These five
Programs are: 1) Cancer Metabolism and Growth (CMG), 2) Genomic Instability and Cancer Genetics (GICG),
3) Cancer Pharmacology (CP), 4) Clinical Investigations and Precision Therapeutics (CIPT), and 5) Cancer
Prevention and Control (CPC). These Programs are supported by eight shared resources (Biomedical
Informatics, Biometrics, Biorepository and Histopathology Services, Comprehensive Genomics, Flow
Cytometry/Cell Sorting, Genome Editing, Metabolomics, and Research Pharmacy), with two developing shared
resources (Immune Monitoring, Small Molecule Screening). The Statewide authority of CINJ derives from its
status as the only NCI-designated Cancer Center; extensive and direct support by the State of New Jersey to
serve as the State’s oncology resource; opportunities to conduct translational and population research within the
most diverse and densely populated State in the nation; and the synergistic opportunities for collaboration across
outstanding research institutions. This supports CINJ’s mission to reduce the burden of cancer in its catchment
by advancing cancer research, prevention, screening and education.

Public health relevance
RUTGERS CANCER INSTITUTE OF NEW JERSEY PUBLIC HEALTH RELEVANCE STATEMENT New Jersey has a population of approximately 8.9 million with a yearly cancer incidence of 50,000 new cases and a yearly mortality of 16,500 deaths. Rutgers Cancer Institute of New Jersey (CINJ) is the State of New Jersey's only National Cancer Institute (NCI)-designated Comprehensive Cancer Center. The mission of CINJ is to reduce the burden of cancer by advancing cancer research, prevention, screening and education for one of the nation’s most diverse and densely populated states as well as for the broader nation.